Unraveling the Biomolecular Corona on Locally Delivered Nanomedicines

Project Summary
The Biological Engineering for Advanced Drug Delivery (BEADD) Laboratory studies particle behavior in vitro
and in vivo to develop improved local drug delivery formulations. Local drug delivery is optimal for treating ocular,
respiratory, gastrointestinal, and vaginal indications, as it can increase drug concentration in local tissues while
decreasing off-target side effects. Our previous work demonstrated that locally delivered formulations must be
strategically designed to reach exposed epithelial surfaces in the human body. This rational design can lead to
improved formulation uptake and therapeutic outcomes. Despite advances in designing locally delivered
formulations, we do not yet have a thorough understanding of how proteins, lipids, and other biomolecules affect
the stability, biodistribution, and uptake of locally delivered therapies. The adsorption of biomolecules onto a
particle’s surface is known as the biomolecular corona and has been extensively studied for systemically
administered formulations. However, we still do not fully grasp how particle physical properties (size, shape,
surface chemistry) impact the formation of the biomolecular corona in other biological matrices (besides serum),
nor is it clear how local environments affect corona formation or how the corona impacts particle behaviors in
the body. This Early-Stage Investigator Maximizing Investigators Research Award (ESI MIRA) will employ a
range of engineering tools to study the formation of the biomolecular corona on locally delivered particles and
the resulting effect of the corona on particle stability, distribution, and uptake. Specifically, this ESI MIRA research
program addresses three fundamental knowledge gaps surrounding the biomolecular corona on locally delivered
particles: (1) How do particle physical properties affect surface adsorption of biomolecules; (2) how does the
local microenvironment influence the formation of the biomolecular corona; and (3) how does the biomolecular
corona impact particle stability, distribution, and uptake in vivo? The proposed work will leverage a robust particle
library, human samples, proteomics and lipidomics, innovative multiple-particle tracking technology, and
physiologically relevant animal models to unravel the formation of the biomolecular corona on locally delivered
particles. Over the next five years, this ESI MIRA research program within the BEADD Lab will generate a
fundamental understanding of the biomolecular corona and how it impacts locally delivered formulations. This
work will establish the BEADD Lab as a leader in local drug delivery technologies and set the foundation for
engineering next-generation precision therapies for treating a wide range of human health indications.

Public health relevance
Project Narrative Locally administered formulations are optimal for ocular, respiratory, gastrointestinal, and vaginal drug delivery, given that nanomedicines are engineered to penetrate the protective mucus barrier which sterically and adhesively traps foreign particles. Despite advances in local drug delivery technologies, however, the formation of the biomolecular corona on nanoparticles in mucus is not yet sufficiently understood. Within this context, the Biological Engineering for Advanced Drug Delivery Laboratory proposes a MIRA research program to investigate how nanoparticle properties and local microbiomes impact the formation of the biomolecular corona and the subsequent biodistribution of locally delivered drugs to facilitate enhanced drug efficacy for a range of human diseases.